Passive samplers in support of Remediation, Detection and Bioaccumulation of PFAS

PROJECT SUMMARY/ABSTRACT – PROJECT 4 DETECTION
STEEP II Project 4–Detection and Remediation (P4-Detection), will further develop, validate, field-test and
deploy passive sampling tools for per- and polyfluorinated alkyl substances (PFAS) in water, biota, air and dust.
The field-validation and applications of passive samplers offer several key advances for the detection of PFAS
including (i) assessment of relevant human exposure via time-weighted average concentrations, (ii) aiding in
identifying the extent of site contamination, and (iii) remediation via simple adsorbents and reliable monitoring
tools that can be deployed before, during, and following remediation to verify success.
P4–Detection offers several innovative research components to address knowledge gaps surrounding
environmental exposure to legacy and novel PFAS, and to provide novel tools to stakeholders. For example,
P4–Detection will develop a simple, but effective filter for PFAS in groundwater, and use its passive samplers
to monitor a field-based ex situ remediation trial for PFAS in groundwater on Cape Cod (Aim 1). P4–Detection
will simultaneously characterize PFAS bioaccumulation in wildlife and field-test passive samplers in the Delaware
River (Aim 2), while using passive samplers to measure the biotransformation and bioaccumulation of PFAS in
controlled laboratory exposures. P4–Detection will also contribute unique tools and data on PFAS in outdoor
and indoor air, and dust to inform STEEP II’s PFAS exposure assessment (Aim 3). P4–Detection will collaborate
with P1–Exposure to assess the importance of atmospheric transport of PFAS, another research gap and
significant need for STEEP’s stakeholders (Aim 3). P4–Detection will thereby address the SRP mandates of
developing “methods to reduce the amount and toxicity of hazardous substances” and “methods and
technologies to detect hazardous substances in the environment.”
The work of P4–Detection is well-integrated with the other STEEP II research projects and cores: it will
maintain strong links with P1–Exposure, with a joint focus on bioaccumulation, and the use of passive samplers
for indoor and outdoor air sampling of PFAS; continue work with P3–Mechanisms on chemical analysis of PFAS
and share mixture profiles of PFAS in cell assays and rodent models; work with P2–Critical Effects to assess
the contribution of indoor air and dust to PFAS exposure in the Faroe Islands relative to seafood consumption
as part of PI Lohmann’s Fulbright Arctic Initiative fellowship; and exchange samples with P1–Exposure to
compare the results of extractable organofluorine (EOF) analysis and perform non-target analysis for the other
projects. Lastly, P4–Detection will work with STEEP II’s research translation team, states, and U.S. EPA to
disseminate results and applications of passive samplers for PFASs to state and federal agencies; with the
DMAC on adhering to FAIR data principles and statistical analysis of the results; with the CEC on indoor air,
dust, fish/shellfish and local grown food analysis on Cape Cod; and with the RETCC and the trainee action teams
on joint research exchanges, activities, and policy initiatives.

Public health relevance
PROJECT NARRATIVE – PROJECT 4 DETECTION Per- and polyfluoroalkyl substances (PFAS) have become the most high-profile pollutants in the US, based on the detection of thousands of contaminated sites, the discovery of PFAS in public water supplies serving millions of Americans, and their highly persistent, toxic and bioaccumulative nature, resulting in food chain contamination worldwide. P4–Detection proposes (i) the development and design of simple yet effective materials for remediating PFAS-contaminated groundwater plumes and in situ monitoring of field trials of ex situ treatment approaches on Cape Cod using passive samplers from STEEP I; (ii) further development and field application of passive samplers as screening tools for legacy and novel PFAS in the Delaware River region with a focus on their bioaccumulation; and (iii) characterizing complementary air sampling tools for stakeholder needs to assess the importance of PFAS inhalation as an exposure pathway. P4-Detection will continue to work with federal (EPA ORD) and state stakeholders (DE, RI) to advance the use of passive samplers in characterizing bioaccumulation and biotransformation of legacy, novel, and total PFAS by aquatic biota, and to rely on passive samplers to assess the atmospheric transport of PFAS away from PFAS.